Wearable sensor for opioids detection based on electrochemical sensor arrayintegrated with Bluetooth device

Project Summary/Abstract
Wearable sensor for opioids detection based on electrochemical sensor array
integrated with Bluetooth device
In this Phase II project, we will develop a new electrochemical sensor array with ultra-
high sensitivity (ng/mL limit of detection), enhanced drug specificity, long-term durability,
low power consumption, and cost-effective production. By the end of Phase II, 20
devices (along with 42 sensory cartridges for each) will be produced and ready for
commercialization (TRL 9) upon completion of Phase II. To provide an ultra-high
sensitivity, nanoporous silicon will be employed as a substrate for the working electrode.
Additionally, advancements of the approach include a high level of integration of all
functional modules on one microchip, wireless communication with user interface
(smartphone, computer), low cost and maintenance through long-term durability, low
power consumption, and cost-effective production.
The specific aims of Phase II are as follows:
• Develop a prototype of the sensory wearable device, which comprises an
electrochemical sensor array tuned to six target opioids and six non-opioid
narcotics
• Demonstrate that the prototype is capable of narcotic detection with ultra-high
sensitivity (within ng/L range) and high selectivity/low cross-reactivity
• By the end of Phase II, produce 20 devices (TRL 9) ready for commercialization
In Phase II, the prototype of the wearable device will be further optimized and
developed to the level of commercial readiness. Major objectives of Phase II include
optimization of individual sensors to the lowest limit of detection and fabrication of two
interchangeable sensory cartridges for six opioids and six non-opioid narcotics;
integration of the sensory module with the printed circuit board for data conditioning,
processing, and wireless transmittance; two-level trials with human subjects; submission
of an FDA application; fabrication of 20 devices and cartridges ready for
commercialization (TRL 9); patent filing; and establishing contacts with end-users,
purchasers and venture groups so that product commercialization can be started after
Phase II (we will use the company profit for sales and marketing).

Public health relevance
Project Narrative The goal of this Phase II proposal is to develop a commercially viable wearable device as a forearm bracelet, for rapid, on-site testing for opioids and other narcotics with wireless alerts. We demonstrated the feasibility of this approach in Phase I. The Phase II effort will focus on further development and optimization to provide ultra-high sensitivity (ng/mL detection range), enhanced drug specificity, long-term durability, low power consumption, and cost-effective production. Upon completion of Phase II, 20 devices will have been produced and will be ready for commercialization.